Neurostimulation in Adult Survivors of Childhood Leukemia

ABSTRACT
Adult survivors of childhood acute lymphoblastic leukemia (ALL) treated with cranial radiation, intrathecal
methotrexate (MTX), or high dose intravenous MTX and/or cytarabine are at risk for neurocognitive morbidities,
particularly in the domain of executive function. Deficits in executive function have been associated with reduced
educational attainment, employment, emotional functioning, and social functioning in survivors. We have recently
identified that higher treatment intensity, as reflected through serum concentration of MTX, is associated with
worse executive functioning, increased brain activation in dorsolateral prefrontal regions based on functional
MRI, and decreased myelin integrity in frontostrial tracts based on diffusion tensor imaging. This suggests that
frontal brain regions may be less efficient in survivors treated with more intense therapies than those treated with
less intensive therapy. Therefore, interventions designed to target the dorsolateral region and focus on
remediation of executive functioning skills may be particularly beneficial for survivors. Importantly, because most
long-term survivors do not reside in close proximity to their primary cancer treatment center, the need for
interventions that can be delivered remotely is critical. We recently piloted a two-month trial of remote transcranial
direct current stimulation (tDCS) to the dorsolateral prefrontal cortex paired with cognitive training for the
treatment of executive dysfunction in a randomly selected sample of 30 adult survivors of childhood ALL (mean
age 33 years, SD 7.5 years). Among the 27 survivors eligible for remote stimulation, 25 (93%) completed at least
50% of the home-based sessions, and 22 (81%) completed all prescribed sessions. These data support the
safety, acceptability, and feasibility of remote tDCS among long-term survivors. Among the survivors who
completed the intervention, we observed significant improvements on a direct measure of executive functioning
(working memory: 0.5 SD increase) and self-reported emotional regulation (0.7 SD increase). Now, we propose
a randomized placebo-controlled study to examine the efficacy of home-based tDCS + remote cognitive
training vs. sham (placebo) + remote cognitive training on symptoms of executive dysfunction in a larger sample
of long-term survivors of ALL. We also will examine impact of tDCS and cognitive training on underlying neural
networks via brain imaging. Results of this study will lead to the development of subsequent clinical trials to
examine optimal treatment intensity and duration as well as dissemination and implementation strategies. This
work has the potential to significantly impact current standard of care with a scalable intervention for common
symptoms of executive dysfunction in long-term survivors of childhood cancer.

Public health relevance
RELEVANCE STATEMENT This study will evaluate the efficacy of home-based transcranial direct current stimulation paired with remote cognitive training for the treatment of executive dysfunction symptoms in adult survivors of childhood acute lymphoblastic leukemia. Results will inform the development of subsequent trials to examine optimal treatment intensity and duration as well as dissemination and implementation strategies. Ultimately, results will inform current standard-of-care as few efficacious interventions are available for the remediation of symptoms of executive dysfunction in long-term survivors.